Temporal Regulation of mRNA Biogenesis in Immune Responses

PROJECT SUMMARY
The innate immune response is highly regulated and the precise timing of gene regulation is crucial for cellular
survival. A primary feature of initial innate immune response cascades is the timely mounting of transcriptional
and processing steps that underlie immune gene expression, with extensive rewiring of mRNA levels and
compositions. Thus, the rates at which mature mRNAs are produced during immune responses might be a critical
regulatory step. Published and preliminary studies suggest gene-specific kinetic regulation of mRNA biogenesis
may underlie changes in gene expression levels and transcriptome complexity in the early innate immune
response. Yet, it remains unclear how the temporal coordination between transcriptional and co-transcriptional
processes governs the timing of immune gene expression and if this co-regulation underlies the ability to mount
a productive immune response upon first encounter with a stimulus.
Gene-specific co-regulation of mRNA biogenesis rates may also allow for efficient immune responses after
repeated stimulation. Some innate immune cells, such as macrophages, undergo epigenetic reprogramming
following initial exposure to immunogenic signals to mount long-term memory, a phenomenon called trained
immunity. Trained macrophages exhibit a faster, more robust innate immune response to resist reinfection,
suggesting that epigenetic changes may enable gene-specific kinetic regulation of mRNA biogenesis. How the
kinetics of transcription and splicing are regulated by epigenetic changes during immune responses is unknown.
This project seeks to uncover mechanistic insights into the regulation and impact of stimulus-induced immune
mRNA biogenesis. This work will test the hypothesis that cellular immune responses are driven by a series of
regulated changes in the kinetics of transcriptional and co-transcriptional processes, ultimately determining gene
expression dynamics over response time. Aim 1 will examine coordination of transcription and splicing kinetics
using lipopolysaccharide (LPS)-stimulated human monocyte-derived macrophages (MDMs). Simultaneous
sequencing of nascent and mature RNA at non-overlapping 15-minute intervals over a 2-hour stimulation time
course will be used to characterize how transcription and splicing rates govern the timing of early immune gene
expression. The functional output of key cytokines will be measured in cell supernatants over the time course.
Aim 2 will explore how trained immunity-associated epigenetic rewiring impacts transcriptional and co-
transcriptional kinetics in MDMs. Trained and un-trained MDMs will be stimulated with LPS in a 2-hour time
course as in Aim 1 to assess transcription and splicing rates, then harvested to assess chromatin accessibility.
Cytokine output will also be assessed over time, as in Aim 1. Overall, this work will elucidate the mechanisms
by which epigenetic rewiring drives resistance to reinfection in trained immunity, illuminate how kinetic regulation
of transcriptional and co-transcriptional processes contributes to innate immune phenotypes, and provide the
fellow with training in RNA biology, innate immune signaling, computational biology, and immunogenomics.

Public health relevance
PROJECT NARRATIVE The innate immune cell response to pathogens such as bacteria and viruses is highly regulated and relies on the precise timing of gene expression for survival. How the timing of immune gene expression is regulated to initiate and potentiate rapid and robust responses to pathogens remains unknown. This project seeks to directly measure the dynamic coordination of processes underlying gene expression in stimulated immune cells over time, and determine how this temporal coordination affects immune cell function.